Center for Research to Optimize Precision Lung Cancer Screening in Diverse Populations

PROJECT SUMMARY / ABSTRACT
Lung cancer, the most significant cause of cancer deaths in the US, is an urgent public health threat. It
disproportionately affects populations that are already plagued by high poverty rates and low education levels.
These populations experience both health disparities in the early diagnosis and treatment of cancer and are
historically difficult to reach with cancer screening initiatives. While the results from the National Lung
Screening Trial (NLST) indicated that low dose CT (LDCT) is an efficacious and cost-effective strategy for lung
cancer screening (LCS), many uncertainties exist with respect to how patient, provider, health system, and
societal factors may impact the quality, compliance, effectiveness, and the risk of harms associated with lung
cancer screening, within community-based health systems who serve diverse populations. Spanning from
Pennsylvania to Hawaii and including five heterogeneous health systems with diverse populations, our
proposed PROSPR Research Center, the Center for Research to Optimize Precision Lung Cancer Screening
(CPLS), brings together a team of experienced, interdisciplinary researchers and clinicians with long-standing
collaborative ties that is well-positioned to pursue research related to the barriers and opportunities associated
with the implementation of LCS programs within community settings. The health systems within CPLS include:
Henry Ford Health System in Metro Detroit, Kaiser Permanente Colorado, Kaiser Permanente Hawaii,
Marshfield Clinic Health System in rural Wisconsin, and University of Pennsylvania Health System. The
ultimate goal of CPLS is to identify critical gaps in the LCS process and to design innovative multilevel
interventions to reduce lung cancer mortality, particularly among underserved populations. To achieve this
goal, CPLS will complete the following specific aims: 1) build a comprehensive data ecosystem by pooling and
linking common data elements to capture the entire LCS process and to assess the patient, provider, facility,
health system, and societal factors that affect LCS; 2) leverage the CPLS data resource to conduct four high-
impact, observational studies of the multilevel factors associated with the LCS process; 3) based on findings
from Aims 1 and 2, develop and test interventions to address identifiable gaps in care that may lead to health
disparities in LCS, 4) actively participate in Trans-PROSPR research initiatives and collaborate with external
investigators via the use of publicly-available CPLS datasets. Our center focuses on the inclusion of diverse,
underserved populations that are defined by multiple factors that may adversely impact access to, and
utilization of, cancer screening. In response to both the Surgeon General’s strong emphasis on the need to
reduce lung cancer mortality and the Cancer Moonshot Blue Ribbon Panel’s focus on reducing the
disproportionately high cancer death rates in underserved populations, CPLS will serve as a model for high-
impact, translational research to reduce disparities in cancer mortality.

Public health relevance
PROJECT NARRATIVE / RELEVANCE This project focuses on evaluating the benefits, harms, and costs of lung cancer screening and prevention in community health systems, with a particular focus on improving lung cancer screening and addressing health disparities in lung cancer-related deaths. The focus on addressing health disparities is particularly important for lung cancer, because lung cancer deaths are highest amongst medically underserved populations. The results of this work will ultimately be used to develop new interventions to decrease lung cancer deaths.